ECOLOGICAL INTERACTIONS IN POTENTIAL PERIODONTOPATHOGENS

The complexity of the mixed, polymicrobic, multifactorial infection known as periodontal disease continues to pose serious difficulties for the research scientist. It is commonly accepted that the polymicrobic environment of the periodontal pocket plays an important role in microbial succession as well as pathogenesis of periodontitis (25). One of the microorganisms closely associated with the severity of this type of infection is Treponema denticola. Like so many other organisms associated with periodontal disease, its actual role in pathogenesis is unknown (15). Limited laboratory data indicate that co-culture with Peptococcus can supply some of its growth requirements (39). In addition, initial observations in our laboratory indicate that medium spent by growth of T. denticola supplied factors which modulated growth of other oral microorganisms. Thus far, no systematic attempt has been made to determine the effect of mixed culture growth on T. denticola or co-cultured organisms, or critically examine mechanisms responsible for modulation. The purpose of the proposed study is to (a) identify the ability of commonly isolated periodontal organisms such as Bacteroides gingivalis, Bacteroides intermedius, Bacteroides endodontalis, Fusobacterium nucleatum, Actinobacillus actinomycetemcomitans, Capnocytophaga gingivalis, Eikenella corrodens, Peptostreptococcus anaerobius, and Streptococcus mitis to modulate growth, (b) determine if T. denticola produces factors which modulate growth of other oral bacterial noted above, and (c) partially characterize modulatory factors as to molecular weight and for stability to heat, pH (2.0 - 12.0), and trypsin. Determination of mechanisms involved in selection and maintenance of specific microflora in the periodontal lesion will allow a more complete understanding of the pathogenesis and progression of periodontal diseases. Furthermore, the data obtained from this study will provide novel information concerning the specific role of spirochetes in this process.